Elucidation of Tissue-Specific Transcriptomic Profiles in Cardio-metabolic Disease

Recent clinical trials and human genetic studies implicate monocytes and macrophages (Mϕ) in atherosclerotic
cardiovascular disease (CVD). Yet, concerns on safety and specificity limit the potential of myeloid cell directed
therapies for CVD and complex cardiometabolic disorders (CMD). This reflects knowledge-gaps in the identity
of human monocyte subpopulations in homeostasis and disease. In the first cycle of R01-HL113147, the MPIs
pursued highly productive bulk RNAseq and functional genomics of human monocyte-Mϕ. However, “data
averaging” in bulk RNAseq masks expression variation and limits capacity to identify monocyte
subpopulations. Human monocytes and their regulatory features differ from mouse. So, despite elegant studies
of rodent monocyte subpopulations and their “master regulator” proteins (MRs), the genetic and functional
identities of human monocyte subpopulations remain unclear. Based on surface markers, human monocytes
can be classified into three subsets, yet emerging data hint at greater diversity. Our preliminary single cell
(sc)RNAseq in over 20,000 blood monocytes from multiple humans suggest (i) at least six monocyte
subpopulations and (ii) variability in subpopulations distributions across CVD risk factor states. In this renewal,
we propose cutting-edge scRNAseq profiling of human monocytes coupled to innovative population genetics
and functional genomics to define the role of human monocyte subpopulations in CMD. In Aim 1, we will enroll
240 participants (60 healthy, 60 hypercholesterolemic, 60 type 2 diabetic and 60 cigarette smokers), perform
3’-end scRNAseq of ~5000 monocytes per subject in 60 participants to identify monocyte subpopulations, and
use scRNAseq data to deconvolute subpopulation distributions from bulk RNAseq for all 240 subjects. Then,
we will determine differentially expressed genes and MRs of monocyte subpopulations in health and in CVD
risk states. Aim 2 will combine scRNAseq and genome wide SNP data to identify monocyte subpopulation-
specific cis-eQTL variants and genes with subpopulation-specific transcriptional bursting. These genetic tools
will be used in large genetic datasets to test the association of specific subpopulations with CMD. In Aim 3 we
focus on subpopulation-specific long intergenic non-coding RNAs (lincRNAs), molecules implicated by our
group and others in monocyte-Mϕ functions and human diseases. Preliminary data reveals that most lincRNAs
are expressed only in subsets of monocytes. We will use an imputation procedure for recovery of lincRNA
expression to identify monocyte subpopulation-specific lincRNAs and association of their cis-eQTL variants
and bursting features with CMD. Mechanistic studies of key subpopulation mRNAs and lincRNAs will use
knockdown and overexpression in human monocyte-derived Mϕ and gene-editing, for knockout, in human
induced pluripotent stem cell-derived Mϕ. We address a major knowledge gap in human monocyte biology by
defining human monocyte subpopulations, interrogating their genetic relationship with CMD, and exploring
functions of subpopulation-specific mRNAs and lincRNAs in human Mϕs.

Public health relevance
PROJECT NARRATIVE Although recent clinical trials and human genetic studies implicate monocytes and macrophages in atherosclerotic cardiovascular disease (CVD), we have yet to optimize monocyte targeted therapeutics for CVD and human cardiometabolic disorders (CMD). In this proposal, we propose cutting-edge single cell RNAseq profiling of human monocytes coupled to innovative population genetics and functional genomics to define the role of human monocyte subpopulations in human monocyte biology and CMD. Our study addresses a major knowledge gap in human monocyte biology by defining the landscape of human monocyte subpopulations, their regulatory features, genetic association with disease, and functional genomics of key monocyte subpopulation regulatory genes in human model systems.